Engineered Memory T cells as a Platform to Treat Enzymopathies

ABSTRACT
We aim to significantly improve outcomes for patients suffering from diseases resulting from missing or
defective enzymes, called enzymopathies, by developing a superior and novel cell-based therapeutic
approach. Our proof-of-concept studies have focused first on Mucopolysaccharidosis type I (MPS I), an
autosomal recessive lysosomal disease caused by deficiency of alpha-L-iduronidase (IDUA) enzyme, resulting
in accumulation of glycosaminoglycans (GAGs). Affected individuals suffer from multi-systemic disease,
including hepatosplenomegaly, corneal clouding, skeletal dysplasias, cardiopulmonary obstruction. In the
severe form of MPS I called Hurler syndrome, there is progressive neurologic impairment and pre-adolescent
death. Current treatments for MPS I include hematopoietic stem cell transplant (HSCT) and/or enzyme
replacement therapy (ERT). Even in the best case, these treatments fail to stop the development of significant
disease burden, resulting in a low quality of life. Further, these treatments are incredibly costly, and HSCT
itself is associated with many serious risks, including death. Using a mouse model of MPS I, we have produced
provocative preliminary data demonstrating that levels of enzymatically active IDUA can be significantly
increased and disseminated widely throughout the body, through administration of primary human memory T
cells engineered to overexpress IDUA. As memory T cells can be long lived and distribute widely throughout
tissues, including the central nervous system (CNS), and because their manufacture and clinically safety is
well established, they are an attractive candidate for a cell-based therapeutic approach to enzyme
replacement. Here, we propose to build on our preliminary data by first optimizing manufacturing methods by
utilizing an efficient and cost-effective non-viral transposon system called TcBuster (TcB), of which our team
has extensive experience, including GMP manufacture for clinical use. Next, we will use the NSG-MPS I
mouse model to further evaluate the safety and efficacy of this cell-based treatment approach, by testing
neurocognitive behaviors in treated versus untreated MPS I mice, and performing a rigorous safety evaluation,
including histopathological analysis. Thus, the studies proposed in this STTR application are to continue
development of a novel cell-based therapy for MPS I that we hypothesize will provide increased safety and
efficacy compared to current HSCT and ERT therapies, yielding increased and more sustained enzyme levels,
and increased distribution to the CNS. Though we are focusing first on the treatment of MPS I, this approach is
amenable for development as a platform therapy, capable of being tailored for the treatment of a variety of
diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE Enzymopathies are diseases caused by deficiencies in enzyme function. Current treatment options for enzymopathy patients are insufficient and rely on potentially life-threatening bone marrow transplant and/or enzyme replacement therapy, costing hundreds of thousands of dollars annually. However, it is possible that a patient’s immune cells, specifically memory T cells, can be isolated, engineered to express the normal functioning enzyme, and transplanted back into the patient to provide a lifelong cure for some forms of enzyme deficiencies.